Outreach, Recruitment and Engagement Core

The growing incidence of Alzheimer's Disease and Alzheimer's disease Related Dementia (AD/ADRD) and the
current demand and anticipated increase in the number of therapeutic trials and other ongoing investigations
demands for more effective and efficient outreach, recruitment, and engagement. Consistent with the major
goals of this FOA (RFA-AG-20-004), the AD/ADRD scientific and clinical community, and the New York
University (NYU) Alzheimer's Disease Research Center (ADRC) for early disease detection, identification of
disease heterogeneity, and developing effective therapies to prevent or delay disease progression, the Outreach,
Recruitment and Engagement (ORE) Core is well positioned to serve as the outward face of the NYU Alzheimer's
Disease Research Center (ADRC). The ORE Core will continue its collaboration with other NYU Centers,
ADRCs, and the larger scientific community in support of disseminating ADRC-related discoveries from the
Clinical, Biomarker, Neuropathology and Data and Statistical Cores. The ORE Core will also continue in its
primary mission as the vehicle for recruitment and retention of research participants in the Clinical Core and
affiliated AD/ADRD studies through community-based recruitment activities, through collaboration with NYU
clinical services especially within disadvantaged neighborhoods, and through deployment of several new
strategies to enhance recruitment and retention. To be most effective, we will develop innovative approaches
that may increase the effectiveness and efficiency of recruitment and retention activities. This is particularly
important for a culturally diverse population and will require multiple community organization collaborations and
deployment of community health workers who are culturally concordant with those we seek to recruit. We will
also utilize the myriad of Epic resources to conduct population-based recruitment through background analytics
within the electronic health record system as well as messaging of potential patient subjects through Epic's
MyChart while protecting patient confidentiality and avoiding the usual human subjects' requirements. We will
rely heavily on our growing registry to ensure a larger “study-ready” population through a well-characterized
group of subjects who may have specific participation interests and whose attention will be sustained by regular
messages and dissemination of new research developments. The ORE core will also serve as a learning
laboratory for these efforts to understand what is most effective and why. We will support national efforts in
AD/ADRD research through close collaboration with the National Institute on Aging's Alzheimer's and related
Dementias Education and Referral (ADEAR) Center by sharing our recruitment infographics, educational
handouts, and video animations. The ORE Core will facilitate expansion of AD/ADRD research activities through
engagement across the NYU campus and collaborating institutions, through research presentations and training
sessions with professionals, and student-in-training workshops, while building relationships in underserved
communities through community-located health fairs and related events.